CHRONIC TOXICITY STUDIES OF TETRAFLUOROETHYLENE

The objective of this project is to develop, evaluate, and report the methodology and results for generation and monitoring techniques necessary for conducting chronic inhalation studies with tetrafluoroethylene.